Use of Electronic Health Records for Addressing Overweight and Obesity in Primary

DESCRIPTION (provided by applicant): Overweight and obesity are highly significant clinical and public health issues. More than one third of U.S. adults are obese and another third are overweight. Overweight and obesity are associated with increased risk of numerous diseases and poor health outcomes, including diabetes, cardiovascular disease, hypertension, certain cancers, disability, and all-cause mortality. The National Institutes of Health (NIH) and other organizations have published evidence-based guidelines on the identification, evaluation, and treatment of overweight and obesity in adults, but many studies show that primary care clinicians often do not document overweight or obesity or discuss weight management with their patients. Electronic health records (EHRs) have the potential to improve clinicians' diagnosis and treatment of overweight and obesity by providing tools such as reminders and clinical decision support. However, very few EHR-based tools have been developed to address overweight and obesity in adults. In addition, personal health records (PHRs) that allow patients to view and interact with their EHRs may be able to help patients with weight management by assisting with self- monitoring and providing tailored information and feedback, but their use for this purpose has not been explored in depth. The objectives of the proposed research are to develop and evaluate EHR- and PHR-based tools to improve diagnosis and treatment of overweight and obesity in the primary care setting and, ultimately, to reduce weight gain in overweight and obese patients. The specific aims are: 1) to develop EHR-based tools to help primary care clinicians identify, evaluate, and treat patients who are overweight or obese; 2) to conduct a randomized controlled trial to assess the effectiveness of EHR-based tools for the identification, evaluation, and treatment of overweight and obesity in primary care; and 3) to develop PHR-based tools to help patients manage their weight. This research will be conducted within 18 primary care practices at Brigham and Women's Hospital that already have an existing EHR and PHR. This research could have an important impact on the management of overweight and obesity in the primary care setting. EHR-based reminders, alerts, and decision support for clinicians and PHR-based weight management tools for patients have the potential to address overweight and obesity in a broad-reaching and cost-effective manner, making them attractive public health strategies. Conducting this research within primary care practices at Brigham and Women's Hospital will enable us to evaluate the feasibility and effectiveness of such tools in a real-world setting.

Public health relevance
PUBLIC HEALTH RELEVANCE: Overweight and obesity are highly significant clinical and public health issues, affecting more than two-thirds of adults in this country; however, primary care clinicians often do not document overweight or obesity or discuss weight management with their patients. The objectives of the proposed research are to develop and evaluate a set of tools within electronic health records (EHRs) and personal health records (PHRs) to assist primary care clinicians with the diagnosis and treatment of overweight and obesity and to help patients manage their weight. Such tools have the potential to address overweight and obesity in a broad-reaching and cost-effective manner, making them attractive public health strategies. PROJECT NARRATIVE Overweight and obesity are highly significant clinical and public health issues, affecting more than two-thirds of adults in this country; however, primary care clinicians often do not document overweight or obesity or discuss weight management with their patients. The objectives of the proposed research are to develop and evaluate a set of tools within electronic health records (EHRs) and personal health records (PHRs) to assist primary care clinicians with the diagnosis and treatment of overweight and obesity and to help patients manage their weight. Such tools have the potential to address overweight and obesity in a broad-reaching and cost-effective manner, making them attractive public health strategies. __SpecificAimsTextDelimiter__ 10. Specific Aims Overweight and obesity are highly significant clinical and public health issues. More than one third of U.S. adults are obese and another third are overweight. Overweight and obesity are associated with increased risk of numerous diseases and poor health outcomes, including diabetes, cardiovascular disease, hypertension, certain cancers, disability, and all-cause mortality. Health care expenditures related to obesity and overweight in adults are estimated to be over $100 billion per year. The National Institutes of Health (NIH) and other organizations have published evidence-based guidelines on the identification, evaluation, and treatment of overweight and obesity in adults; however, despite the existence of these guidelines, primary care clinicians often do not document overweight or obesity or discuss weight management with their patients. Electronic health records (EHRs) have the potential to improve clinicians' diagnosis and treatment of overweight and obesity by helping them identify and evaluate these patients more easily and by providing tools such as reminders and clinical decision support. However, there have been very few studies of the use of EHR-based tools for addressing overweight and obesity in adults. In addition, personal health records (PHRs) that allow patients to view and interact with their EHRs may be able to help patients with weight management by assisting with self-monitoring and providing tailored information and feedback, but their use for this purpose has not been explored in depth. The objectives of the proposed research are to develop and evaluate EHR- and PHR-based tools to improve diagnosis and treatment of overweight and obesity in the primary care setting and, ultimately, to reduce weight gain among overweight and obese patients. The specific aims are as follows: Aim 1: To develop EHR-based tools to help primary care clinicians identify, evaluate, and treat patients who are overweight or obese. Hypothesis 1.1: It is possible to develop EHR-based tools for the diagnosis and treatment of overweight and obesity by primary care clinicians. Hypothesis 1.2: EHR-based tools for the diagnosis and treatment of overweight and obesity will be acceptable to primary care clinicians. Aim 2: To conduct a randomized controlled trial to assess the effectiveness of EHR-based tools for the identification, evaluation, and treatment of overweight and obesity in primary care. Hypothesis 2.1: EHR-based tools will lead to improvements in diagnosis and treatment of overweight and obesity by primary care clinicians. Hypothesis 2.2: EHR-based tools will reduce weight gain among overweight and obese patients in primary care. Aim 3: To develop PHR-based tools to help patients manage their weight. Hypothesis 3.1: It is possible to develop PHR-based tools to help patients manage their weight by assisting with self-monitoring and providing tailored information and feedback. Hypothesis 3.2: PHR-based tools to help patients manage their weight will be acceptable to patients and primary clinicians.